Fungal Pathogenicity Determinants through the Lens of Immune-Targeted Cancer Therapies

Project Summary. The advent of molecular therapies for cancer and autoimmunity have led to a rise in the
number of serious infections caused by environmental microbes, exemplified by invasive aspergillosis (IA).
While Aspergillus fumigatus is normally a benign environmental saprophyte, this ubiquitous mold can cause
life-threatening invasive disease in the setting of leukopenia and/or high dose corticosteroid treatment. Fungal
pathogenicity in leukopenic or corticosteroid-treated populations is historically thought to be a global property
of all environmental A. fumigatus strains, based on their common property of reaching terminal airways and
growing at human body temperatures. Recent bedside to bench research from our laboratories is challenging
this long-standing paradigm of A. fumigatus strain-agnostic pathogenicity. Patients undergoing pharmacologic
inhibition of Bruton’s tyrosine kinase (BTK) for lymphoid malignancies have an unexpected risk for IA.
However, murine model studies to define the mechanism of A. fumigatus susceptibility during BTK inhibitor
therapies revealed a striking fungal strain-specific pathogenicity. Standard pathogenic reference strains that
are highly virulent in murine models of leukopenia or corticosteroid treatment failed to cause disease in BTK-
deficient or -inhibited models. However, clinical isolates from BTK therapy patients initiated invasive disease
and caused host mortality. Immunologic studies revealed that BTK inhibitors (BTKi) such as Ibrutinib
surprisingly blunted myeloid antifungal activity, specifically the function of neutrophil NADPH oxidase and
primary granule exocytosis. Our working hypothesis is that A. fumigatus strain-specific pathogenicity in the
setting of BTKi is mediated by alterations in the fungal genetic network responsible for susceptibility to NADPH
oxidase- and degranulation-mediated killing. In this proposal, we propose two aims to define the A. fumigatus
strain-specific pathogenicity determinants responsible for IA in the setting of BTKi therapy. In aim 1, we utilize
novel whole genome protein kinase, phosphatase, and transcription factor null mutant collections to define the
genetic network responsible for fungal cell viability during interactions with host neutrophils. Preliminary data
identified 3 protein kinases and 1 protein phosphatase whose function mediated susceptibility to neutrophil
killing. These key regulatory proteins will be utilized to define the genetic network mediating neutrophil fungal
killing susceptibility. In Aim 2, we leverage our novel collection of A. fumigatus isolates from patients on BTKi
therapies. Preliminary whole genome sequencing data of these isolates identified a loss of function allele in the
same protein phosphatase identified in our genetic screen in Aim 1. Further studies will detail the pathogenesis
of these clinical isolates in our BTKi murine models and conduct mechanistic genetic analyses to pinpoint the
key A. fumigatus pathogenicity determinants driving IA in this specific host setting. Our proposed studies are
expected to reveal unexpected novel fungal pathogenicity determinants in the host setting of precision
medicine therapy that is rapidly being employed in the clinic for the treatment of cancer.

Public health relevance
PROJECT NARRATIVE Invasive fungal infections are emerging in new patient populations due to advances in precision medicine therapies for chronic diseases. These new immune system targeted therapies are revealing previously unexplored pathogenicity determinants in environmental fungi. This proposal will define Aspergillus fumigatus pathogenicity determinants in the setting of Bruton’s Tyrosine Kinase inhibitor therapies.